Google Cloud Pipeline for mouse behavior and frailty assessment for the aging research community

PROJECT SUMMARY
The supplement will build a Google Cloud Pipeline (GCP) for processing video data for frailty assessment. The
parent grant proposes to extend previous work done in isogenic mice to genetically diverse mice and to extend
the feature set for frailty assessment. The parent grant relies on limited institutional on premises resources. We
will use to GCP to test feasibility of a scalable and sharable resource for aging research.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Aging is a chronic condition that afflicts all living systems; healthy vs. unhealthy aging can be measured using a frailty index which is often used in interventional studies. Here we propose to develop scalable frailty index using computer vision and machine learning in the context of genetically diverse mouse populations with diet- based interventions to mimics human aging. The resulting tool will strengthen the utility of animal models for behavioral and social research toward understanding how social and physical environmental factors contribute to aging processes and the etiology and progression of age-related conditions and diseases.